BRCA1/2 and Hereditary Breast, Ovarian and Pancreatic (HBOP) Cancer Variant Curation Expert Panels

PROJECT SUMMARY
Women with germline variants in breast, ovarian and pancreatic cancer predisposition genes are at significantly
elevated risk of developing these cancers in their lifetime. Clinical hereditary cancer genetic testing for
pathogenic variants in these genes has become an important part of clinical practice. Much of the benefits of
genetic testing are associated with the BRCA1 and BRCA2 genes because of the risk management, surgical
prevention and targeted treatment benefits associated with knowledge of the presence of a cancer predisposing
pathogenic variants. However, identification of pathogenic variants in other predisposition genes including ATM,
BARD1, BRIP1, CHEK2, PALB2, RAD51C and RAD51D is also clincially meaningful because carriers may
qualify for enhanced screening for breast, ovarian and pancreatic cancer. However, this process is often
complicated by an inability to establish the clinical relevance of variants in these genes. This lack of information
about these variants means that individuals carrying germline variants often cannot benefit from enhanced risk
assessment and management or make informed decisions about surgical prevention or tailored treatment
options. To address this issue we have developed a ClinGen BRCA1/2 Variant Curation Expert Panel (VCEP)
and a Hereditary Breast, Ovarian, and Pancreatic (HBOP) VCEP. We will develop ACMG-like rules-based
methods for variant classification in each of the genes described above and apply these rules to classification of
observed variants in these genes. Thus, the Aim of this application is to curate and classify the clinical
relevance of germline variants in BRCA1 and BRCA2 through a BRCA1/2 VCEP and variants in ATM,
BARD1, BRIP1, CHEK2, PALB2, RAD51C and RAD51D through the HBOP VCEP. The results from the
proposed curation efforts will be entered into the ClinGen Variant Curation Interface and made available to the
public through the ClinVar and BRCA Exchange websites.

Public health relevance
PROJECT NARRATIVE The catalogs of variants in the BRCA1, BRCA2 and Hereditary Breast, Ovarian and Pancreatic (HBOP) cancer genes that will be established as pathogenic or benign are expected to greatly impact clinical management of individuals diagnosed with variants in these cancer genes.